PREP-MT: Providing Research Education for Postbaccalaureate Trainees in Montana

SUMMARY
Minority graduates are significantly underrepresented in biomedical PhD programs nationwide. Montana
State University (MSU), a research-intensive public land-grant university, serves a significant number of first-
generation rural and low-income students who rarely enroll in PhD programs. Likewise, Montana is home to
twelve Indigenous tribes, with >6.5% of Montana residents considered American Indians, but only 4.7% of
MSU’s undergraduates identify as Native, and no Native Americans have graduated from MSU’s biomedical
PhD programs in the past five years. To address these inequities, we have designed an evidence-based
postbaccalaureate program, PREP-MT, to prepare underrepresented minority graduates including first-
generation, rural, low-income students and Native Americans in Montana for a successful transition into
doctoral degree programs in the biomedical sciences. PREP-MT will equip recent minority graduates (PREP
scholars) with the experience, confidence, knowledge, and research skills to become highly successful PhD
students and graduates. Specifically, our program will pursue the following Specific Aims: (1) Provide in-depth,
mentored biomedical research experiences to PREP-MT scholars; (2) Enable PREP-MT to develop
professional and career skills relevant to a successful career in biomedical science; (3) Build a professional
support network for the PREP-MT scholars to create a sense of belonging as members of the biomedical
research community. Additionally, we will perform regular program evaluations, incorporate changes to
improve the PREP-MT program, and disseminate our findings to appropriate audiences. Our program is highly
feasible, because PREP-MT is synergistically integrated with established undergraduate and graduate
research training programs at MSU, increasing the opportunities for the scholars and maximizing our
resources. Our Multi-PI leadership team is uniquely positioned to manage the proposed program, since we
have a strong background in leading collaborative research and training, promoting minority involvement in
biomedical research, and collaborating with tribal and rural communities. More than 30 faculty with biomedical
research programs from ten departments who have demonstrated a commitment to training the next
generation of scientists have agreed to serve as mentors for the PREP-MT program. All mentors will receive
mentorship training through the Center for the Improvement of Mentored Experience in Research and MSU’s
Indigenous Mentoring Program. The proposed PREP-MT program is innovative, because of its focus on Native
American and first generation rural and low-income graduates and because it emphasizes instilling a sense of
belonging in our PREP participants. In summary, we are confident that the PREP-MT program will significantly
enhance biomedical workforce development by increasing the access of minority groups in Montana to high-
quality PhD programs and impactful careers.

Public health relevance
NARRATIVE The goal of this project is to provide in-depth research experiences, career training and mentorship to underrepresented minority graduates in Montana, including Native Americans, and rural first generation and/or low-income students, so that they can successfully transition into doctoral degree programs in the biomedical sciences. To accomplish this goal, we have designed an evidence-based postbaccalaureate program, PREP- MT, that will equip recent minority graduates (“PREP scholars'') with the experience, knowledge, research skills and confidence to become highly successful PhD students and graduates.